A shared DSI Inhalation System for diverse studies across disease and health

Project Summary
The goal of this proposal is to build a state-of-the-art respiratory exposure system at Baylor College of
Medicine. This system will address a critical gap in inhalation exposure research using rodent models. It will
facilitate studies encompassing developmental to degenerative life stages, peripheral and central neurological
function, respiratory control, immune functions, and cardiovascular physiology. We will offer a multi-modal
inhalation exposure platform for advanced respiratory exposure research at Baylor College of Medicine.
We are requesting a customized Data Sciences International (DSI) Inhalation Solution that integrates multiple
options for 1) housing the mice during exposure, 2) aerosolizing the desired agent, and 3) measuring and
analyzing resultant respiratory parameters during exposure for maximal flexibility across a wide variety of users
and research projects. The customized DSI solution utilizes a Stackable Inhalation Tower with options to expand
capacity over time without any loss of investment from the initial purchase. The Inhalation Dosing Tower uses
modular levels, each level providing 7 inhalation exposure ports, and can be expanded up to 6 levels for a total
of 42 possible ports. The requested equipment provides capacity for 28 ports which would allow for the exposure
of 23 animals while the remaining ports are used to sample the airflow to quantify particle/aerosol concentration.
The tower enables real-time respiratory measurements that when integrated with the FinePointe software allow
the user to fine-tune acute exposures based on measured respiratory parameters and particulates/aerosolized
components. There are three options for aerosolizing or smoking desired respiratory exposures: 1) an E-Cig/
Vape/ Tobacco Smoke (EVT) Generator, 2) a Smoke Generator, and 3) an Aerogen Nebulizer Head capable of
aerosolizing a variety of desired toxins including virus and bacteria. The system will be housed in a BSL-3 safety
cabinet to ensure full containment and safety. Lastly, BCM will make a substantial financial commitment in salary
support and an extensive, five-year service contract to ensure consistent, optimal operational, and maximal
longevity for the requested equipment.
This equipment system represents a significant opportunity to advance respiratory exposure research for Baylor
College of Medicine (BCM). The portfolio of research conducted at BCM represents a unique opportunity to
improve experimental approaches in disease states influenced by environmental respiratory exposures including
Sudden Infant Death Syndrome (SIDS) and Sudden Unexpected Infant Death (SUID), congenital respiratory
disorders, Acute Respiratory Distress Syndrome (ARDS), bronchopulmonary dysplasia (BPD), asthma,
pneumonia, emphysema, and BSL-2 level pathogen infections such respiratory syncytial virus (RSV).

Public health relevance
Public Health Relevance Environmental exposures, particularly through the respiratory system, represent a major medical health concern in the United States. The role that various exposures play in disease development and how these exposures interact with disease-causing or associated gene variants is understudied. The requested equipment will enable a broad spectrum of studies that examine the role of respiratory environmental exposures alone and in combination with genetic disease mechanisms.